GCRC-CAP-MARIA IUORNO, M.D.

The General Clinical Research Center at VCU/MCV has long been recognized as one of the school's most important resources. A long history of outstanding clinical research and a stable, supportive environment encourage multidisciplinary teams of investigators to work together on the GCRC. Through this five year competitive renewal application we aim to continue to provide the facilities and resources necessary for the conduct of clinical investigations of the highest quality. Sixty-nine scientific proposals detailed in this application involve more than 100 scientists working in major areas of medical research. These include studies in genetic diseases, diabetes, hypertension, renal diseases, cancer pituitary diseases, obesity, sickle cell disease, liver diseases, and vascular responsiveness. The major clinical disciplines including medicine, ob-gyn, surgery, pediatrics, neurology, and psychiatry are represented with additional studies by pharmacy, medicinal chemistry, and nursing.